Administrative Core

PROJECT SUMMARY The proposed Administrative Core (Core A) will interact closely will each of the proposed 4 projects and the two other proposed cores: the Scientific Core and the Data Management and Analysis Core. We have developed a detailed plan to strive to optimize the synergy and interactions among the projects, cores and personnel involved in the studies proposed in this U19 renewal application. Such interactions will be facilitated by the existence, at Stanford, of resources such as the Human Immune Monitoring Core (HIMC), in which the work in Scientific Core will be conducted and whose director, Holden Maecker, is also the director of our proposed Scientific Core. Other resources available to this U19 include the Sean N. Parker Center for Allergy and Asthma Research, which is directed by Dr. Kari Nadeau, who is the Project 3 Lead, and the Clinical and Translational Research Unit (CTRU), which is directed by the Project 1 Lead, Dr. Sharon Chinthrajah. Notably, the members of the Stanford team are already interacting scientifically under the current AADCRC U19 program. Accordingly, should this renewal application be funded, the proposed work to advance our understanding of the pathology of food allergy, and the mechanisms that contribute to desensitization and tolerance in this disorder, will represent a continuation and substantial expansion of these ongoing collaborative efforts. The Administrative Core has two Specific Aims: Aim 1: Provide scientific administration and coordination in support of the objectives of the Stanford AADCRC;? Aim 2: Provide fiscal oversight and administration. A special feature of Aim 1 is that Dr. Mark Davis, director of the Stanford Institute for Immunology, Transplantation, & Infection (ITI), will co-­chair, along with the PI of the application, the Scientific Advisory Board for this U19, providing the group with the expertise he has acquired in many other human immune monitoring projects being pursued with the assistance of the HIMC (that is housed in ITI). The Scientific Advisory Board also will include Dr. Bali Pulendran, a renowned systems immunologist, and Dr. Andy Fire, a noted molecular biologist who also will be a Co-­Investigator in Project 2.